Advancing Research Operations at an Emergent R1 Minority-Serving Institution

Project Abstract. The University of Texas at El Paso (UTEP) is a minority-serving academic institution whose
mission is dedicated to the advancement of knowledge through research, education, community engagement,
as an emergent national research institution. At UTEP, there is a critical
need for equipment to enhance our research infrastructure and maintain our status as an R1 institute in the years
to come.
and public service. Our designation as a Carnegie Tier One university "R1: Doctoral Universities – very high
research activity" distinguishes UTEP
As a premier biomedical research institution that is heavily engaged in promoting diversity in the
scientific workforce, the proposed project will add a critically needed cage/rack washer in our Biosciences Main
animal facility. The proposed request will foster our robust and productive biomedical research program involving
laboratory animals. The UTEP biomedical research program is being supported by the Department of Laboratory
Animal Resources Center (LARC) in partnership with the Institutional Animal Care and Use Committee (IACUC).
The LARC manages and monitors the housing and use of research animals to ensure compliance with applicable
Federal, State, and Local laws and guidelines as well as Institutional Policy. The LARC supports the Main animal
facility in the Biosciences building, and the 3 additional animal satellite facilities in Psychology, Biology and the
Interdisciplinary Research Building (IDRB). Their oversight also includes our Zebra fish aquarium as well as 2
field research stations located off of our main campus. The animal facilities are designed to accommodate
exquisitely controlled environments and equipment for the maintenance and care and use of laboratory animals.
In a comprehensive assessment of needs and projected growth, we identified a critical need for a cage/rack
washer in the Biosciences Main animal facility. The current washer has been in use for more than 10 years, and
has exceeded its 10-year life expectancy. This washer is critical to our operations because it provides sanitizing
services for equipment used in the Main animal facility as well as for research involving animals housed in the
Biology and Psychology animal facilities. The sanitizing services in the newly established IDRB facility is being
supported by its own washer that provides services for 3 investigators and their 3 projects as well as being used
as a back-up washer for the one in the Main animal facility due to frequent malfunctioning. Therefore, the
requested upgraded cage/rack washer will support 39 of 42 active biomedical research projects involving the use
of prairie voles (Microtus ochrogaster), mice (Mus species) BALB/c, C57/BL6 and transgenic mice, and rats (Rattus
species), Sprague-Dawley and Wistar strains. The 39 projects are being conducted by 25 UTEP faculty from 5
different colleges related to public-health problems in the neurosciences, infectious diseases, cancer, and ecology
and evolutionary biology, and biomedical engineering. The upgraded cage/rack washer will provide the support
required to sustain the animal care and use program essential for supporting the UTEP's robust and productive
biomedical research programs.
1

Public health relevance
Project Narrative. The University of Texas at El Paso (UTEP) is among the leading minority academic institutions dedicated to the advancement of knowledge through research, teaching, learning, community engagement, and public service. As a premier biomedical research institution, the goal of this proposed project is to add an upgraded cage/rack washer as part of ongoing efforts to modernize the animal care and use facilities. The upgraded washer will be utilized to provide animal husbandry services required to sustain the health and welfare of the animals to support UTEP's biomedical research program that will contribute fundamental medical knowledge in support of the nation's public health outcomes. 1